Integrated Health Sciences Facility Core

PROJECT SUMMARY – Integrative Health Sciences Facility Core
The Integrative Health Sciences Facility Core (IHSFC) will continue to be the hub of environmental health and
disease-related translational research. UC Davis has long-standing, recognized expertise in animal and in
vitro mechanistic environmental health research housed in numerous laboratories including in the highly-
ranked School of Veterinary Medicine, College of Agriculture and Environmental Sciences and the College of
Biological Sciences. To better prepare for extension of our environmental health research efforts to translate
into innovative intervention and human studies, our leadership and research capacity of this core has
expanded. Overall, access to critical resources will be provided by the UC Davis Environmental Health
Sciences Core Center (EHSCC) IHSFC for in vitro studies, animal models, biostatistics, novel sensor and
biomarker technologies, and translational research resources for human studies and disaster response
research. Specifically, our aims are to 1) promote EHSCC research projects along the translational research
pipeline using in vitro assays, in vivo experimental larval fish, rodent and non-human primate models, and
epidemiology and human studies, 2) provide biostatistical consultation and study design expertise to new and
established environmental health researchers, 3) develop and implement new tools and technologies for
environmental health sciences research, and 4) establish a UC Davis Environmental Health Sciences Rapid
Response team that can mobilize quickly to immediately engage populations affected by environmental
disasters, e.g. wildfires. These resources are critical for the center to achieve its overarching goal to deepen
our understanding of how environmental exposures affect human health and, thus, the IHSFC will play a vital
role in bringing EHS-related research at UC Davis to applications and interventions that reduce disease and
disability, and promoting environmental public health both in our targeted region of California’s Northern and
Central Valley, and throughout the world.